EFFECTS OF MULTIPLE DOSE ENZYME REPLACEMENT USING CEREDASE IN GAUCHER'S DISEASE

The first stage of this study will continue the analysis of the results of management of a cohort of patients with Type I Gauchers disease under treatment with macrophage targeted glucocerebrosidase with particular attention to bone disease.